Establishing the market-readiness of an in vivo technology for assessing drug toxicity-induced tissue damage

PROJECT SUMMARY
There is a substantial and growing need for in vivo toxicity testing, as in drug R&D it is critical to be able to
understand toxicity and to identify and eliminate overly toxic candidates. We developed an imaging-based
approach that detects toxicity-induced tissue injury in a minimally invasive, whole body and dynamic fashion.
The goal of the current Phase II STTR grant is to expand the marketability and market readiness of the
technology by demonstrating a broadened scope of utilities including semi-quantitative characterization and drug
safety. Overall, this in vivo imaging approach identifies an important marker for drug toxicity on a personalized
basis with objective and quantitative metric. The early detection of drug toxicity in susceptible tissues will help
make timely decisions in drug R&D by prioritizing safe and efficacious candidates. The technology is applicable
to multiple stages in pharmaceutical R&D and is expected to generate a significant impact on drug development
and drug safety.

Public health relevance
PROJECT NARRATIVE The goal of this STTR Phase II project is to demonstrate an expanded utility of an in vivo imaging-based testing technology, which allows for characterizing and optimizing cancer therapies and for identifying tissue damage induced by drug side effects.